Efficacious and safe antibody catalyzed amyloid beta clearance

DESCRIPTION (provided by applicant): Accumulation of amyloid β peptide (Aβ) aggregates in the brain is thought to be a central event leading to neurodegenerative changes observed in Alzheimer disease (AD). There is consensus that immunoglobulins (Igs) with specific Aβ binding activity are viable candidates for AD therapy. We propose to develop novel catalytic Igs with improved efficacy and safety as candidate immunotherapeutic agents for AD. Our experimental approach is based on these considerations. A single catalytic Ig molecule hydrolyzes thousands of Aβ molecules over its lifetime, which should confer superior efficacy to catalytic Igs in removing Aβ oligomers compared to conventional stoichiometrically binding Igs. The catalysts do not form stable immune complexes with Aβ, reducing the likelihood of inflammatory reactions. Deposition of Aβ in blood vessels observed using conventional Igs is unlikely because of Aβ digestion by the catalytic Igs. We have identified catalytic Ig variable domains (IgVs) suitable for further development as AD drugs. We will apply protein engineering methods to prepare catalytic IgV derivatives with improved stability and reduced immunogenicity suitable for administration to humans. The resultant Igs will be characterized with respect to catalytic rates and specificity. They will then be tested for efficacy (Aβ clearance, behavioral improvement) and safety using a transgenic mouse model of AD. If our hypotheses are correct, these studies will validate catalytic Igs as agents suitable for AD therapy. PUBLIC HEALTH RELEVANCE STATEMENT: Finding an effective and safe treatment for Alzheimer disease is an important public health need. We plan to test and develop catalytic antibodies that clear amyloid beta peptide for immunotherapy of Alzheimer disease.